Bioinspired Synthetic High-Density Lipoprotein (sHDL) nanotherapeutics with immunomodulatory and regenerative potential in endodontics

PROJECT SUMMARY/ABSTRACT
Dental pulp necrosis, whether caused by tooth decay or injury, can progress to apical periodontitis (AP) if left
untreated. AP is a common condition characterized by inflammation of the tissues surrounding the tooth roots
and bone destruction, affecting about 52% of the global population. In the United States, this condition leads
to at least 15 million root canal procedures annually for treatment. Suppose the tooth is a mature permanent
tooth with a closed apex. In that case, treatment typically involves orthograde root canal therapy by
mechanical instrumentation, and the use of outdated and toxic chemical agents, such as sodium hypochlorite.
In contrast, when pulpal necrosis occurs in immature permanent teeth in children, the death of odontoblasts
disrupts normal root development. Treatment options in such cases include apexification or regenerative
endodontic procedures (REP). However, these approaches often involve harmful substances for root canal
cleaning and antibiotic combinations in pastes that are highly detrimental to mesenchymal stem cells,
ultimately compromising the tooth's regenerative potential. Thus, there is a pressing need to develop clinical
therapies that can predictably resolve AP in permanent teeth, regardless of their developmental stage. To
address this issue, I will split the effort into three specific aims. First, I will identify a non-toxic synthetic high-
density lipoprotein (sHDL)-antibiotic-loaded formulation with enhanced antimicrobial and immunomodulatory
properties (Aim 1). Then, I will identify the mechanisms and pathways these nanoparticles activate when
treating necrotic mature permanent teeth with AP in rats (Aim 2), and I will determine their ability to promote
pulp and dentin regeneration and root formation in rats’ partial or fully necrotic immature permanent teeth (Aim
3). A highly experienced advisory team has been assembled to guide the candidate. Dr. Marco Bottino is the
primary mentor, offering valuable support throughout the training, scientific plan, academic job search, and
career transition. The advisory team also includes Dr. Anna Schwendeman, an expert in the manufacturing of
potent and safe sHDL nanomedicines; Dr. Joshua D. Welch, a leading expert in computational methods
related to high-throughput sequencing technologies; and Dr. Hajime Sasaki, a world-renowned scientist
specializing in inflammation related to apical and marginal periodontitis, who serves as an advisor/consultant.
The candidate, a dentist-scientist, is currently a postdoctoral research fellow at the University of Michigan
School of Dentistry. This proposal outlines a comprehensive mentorship and training plan to enhance the
candidate’s expertise in lipid nanoparticle manufacturing, high-throughput transcriptomics, and bioinformatics.

Public health relevance
PROJECT NARRATIVE Dental pulp necrosis and apical periodontitis (AP) are widespread, often compromising root development in young patients and affecting long-term tooth resilience. This project aims to develop a synthetic high-density lipoprotein (sHDL) nanoparticle loaded with antibiotics, offering a biocompatible solution with antimicrobial, immunomodulatory, and regenerative properties to improve endodontic treatment outcomes.